Transition zone control of ciliary signaling

Project summary/Abstract
Many cells in the human body possess a singular projection from their surface called a primary cilium.
Although the existence of primary cilia has been recognized for over a century, it has become clear only
recently that they function in the detection and interpretation of important intercellular cues. Some of these
cues, such as Hedgehog signals, are key regulators of embryonic patterning and adult tissue homeostasis.
Consequently, defects in Hedgehog signaling can cause birth defects and some forms of cancer. Similarly,
defects in primary cilia cause congenital ciliopathies such as Oro-facio-digital and Joubert syndromes, and can
underlie more common human diseases such as polycystic kidney disease.
To function in signaling, primary cilia need to maintain a different composition than surrounding parts of
the cell. We identified the transition zone, a region of the ciliary base, as a critical regulator of ciliary
composition. To understand how the transition zone controls which proteins localize to cilia, we will answer
three complementary questions.
First, given that the transition zone is a complex and highly structured region of the cilium, we will
determine how it is built. Identifying how extra-ciliary protein complexes generate the transition zone will
illuminate how mutations affecting non-ciliary proteins also cause ciliopathies.
Second, we will examine how the transition zone regulates protein and lipid localization to the cilium.
Understanding how different trafficking machines and their cargos use distinct mechanisms to cross the
transition zone will help reveal how this gate controls ciliary protein composition. Additionally, we will build on
recent data that the lipid composition of the ciliary membrane is specialized and essential for its signaling
functions by examining how ciliary lipids enter the cilium and enriched there by the transition zone. These
experiments will demonstrate how proteins regulate lipid composition to enable organelle-specific functions.
Third, we will determine how the transition zone regulates craniofacial development. Many ciliopathies
are associated with craniofacial defects, and our investigation of how transition zones function in facial
patterning is revealing novel ways in which ciliary signaling regulates mammalian development.
By elucidating the mechanisms by which the transition zone controls ciliary composition, we will help
illuminate how the cell compartmentalizes this organelle to perform diverse signaling functions critical for
development and physiological functioning.

Public health relevance
PROJECT NARRATIVE To create an organism, cells must communicate with each other. This project is helping to demonstrate how some forms of intercellular communication are transduced through the primary cilium, a highly-organized cellular antenna packed with specialized signaling machinery and whose composition is regulated by a gate called the transition zone. Understanding transition zone function will help reveal how cilia function as signaling organelles and uncover the origins of inherited diseases, collectively called ciliopathies, caused by defective transition zone function.